Forecasting Lung Transplant Benefit: A Dynamic Risk Modeling Approach

Project Summary
Increasing clinical demand for lung transplants has exacerbated the problem of rationing this limited yet life-
saving societal resource. The Lung Allocation Score (LAS) system was developed to improve overall survival
by identifying patients who would likely benefit the most from transplant. Despite this effort, there have been
increasing rates of waiting list mortality, declines in long-term survival after transplant and dramatic increases
in healthcare costs and utilization among transplant patients.
Our project focuses on improving the LAS system by: 1) designing better methodologies to more accurately
identify the progression of illness in a patient who is awaiting transplant, 2) predicting ideal timing of transplant
to maximize the number of years gained from a transplant, and 3) evaluating different allocation strategies and
their impact on individual and population level survival. We will achieve this by carrying out the following aims:
Aim 1: Update the lung allocation score (LAS) underlying risk models to better accommodate
subpopulation-level differences over time among lung transplant candidates.
Aim 2: Develop and validate a forecasting model for lung transplant candidates’ dynamic health state and
likelihood of transplantation over time using a systems-based microsimulation modeling approach.
Aim 3: Evaluate the impact of lung allocation strategies that optimize patient- and population-level functional
and survival outcomes.
The results of this work will provide the foundation for improving lung allocation in the United States. We will
optimize timing of lung transplantation to maximize transplant benefit at the individual patient and population
levels. The methods identified in this project can be utilized in other scenarios where limited life saving
resources must be rationed.

Public health relevance
Project Narrative Donor lungs for transplantation are limited. The current Lung Allocation Score (LAS) system for rationing donor lungs poorly identifies who is likely to benefit from transplant and has resulted in overall poor survival and increasing use of healthcare resources. This research will contribute to the development of a more accurate way of determining which patients are most likely to benefit from a lung transplant, which will be of benefit to individual patients and society in general.